PAcific Islander, Native Hawaiian and Asian American Cardiovascular Health Epidemiology (PANACHE) Study

ABSTRACT
In 2020, there were nearly 24 million Asian Americans and 1.6 million Native Hawaiians and other Pacific
Islanders in the U.S., representing 8% of the total U.S. population, and these groups represent the fastest
growing U.S. population group over the past decade. Yet, few data exist about the contemporary epidemiology
of major cardiovascular diseases and explanatory variables between different Asian American, Native
Hawaiian and Pacific Islander (AANHPI) subgroups in large, representative U.S. populations and compared
with non-Hispanic Whites. As highlighted in NOT-HL-23-001 (Epidemiologic studies in Asian Americans, Native
Hawaiians, and Pacific Islanders), there is a pressing need to fill these key knowledge gaps given the
substantial heterogeneity between these different subpopulations in a variety of exposures that may potentially
contribute to differential rates of cardiovascular diseases and reflect opportunities to improve care and
outcomes. We propose to address many of these knowledge gaps through the PAcific Islander, Native
Hawaiian and Asian American Cardiovascular Health Epidemiology (PANACHE) Study which will leverage
collaborations between the Kaiser Permanente Northern California and Kaiser Permanente Hawaii integrated
healthcare delivery systems whose collective AANHPI adult population is >800,000 and non-Hispanic white
population of >1.7 million between 2012 and 2021. The specific aims of the PANACHE Study are (1) to
delineate the contemporary incidences of heart failure (HF), atrial fibrillation (AF) and myocardial infarction (MI)
among different AANHPI subpopulations compared with non-Hispanic Whites; (2) to develop and validate
novel predictive models for incident HF, AF and MI within AANHPI subpopulations; and (3) to characterize self-
reported sociocultural, behavioral, dietary and environmental factors across AANHPI subpopulations and their
association with clinical cardiovascular risk factors and overall predicted risks of incident HF, AF and MI, along
with establishing a linked data and specimen biorepository using remote blood collection methods. Overall, the
PANACHE Study brings together a highly experienced multidisciplinary team with complimentary expertise in
cardiovascular disease and evaluating ethnic differences, use of electronic health records and other data
sources, and advanced predictive analytics; as well as access to and success in engaging large populations of
AANHPI adults in Hawaii and Northern California. The PANACHE Study will increase our understanding of the
epidemiology and contributing factors to major cardiovascular diseases in support of the goal to improve the
quality of care and outcomes for these understudied patient subgroups.

Public health relevance
NARRATIVE The PAcific Islander, Native Hawaiian and Asian American Cardiovascular Health Epidemiology (PANACHE) Study involves a multidisciplinary collaboration between Kaiser Permanente Northern California and Kaiser Permanente Hawaii integrated healthcare delivery systems to address key knowledge gaps related to the epidemiology of cardiovascular disease in >800,000 members across Asian American, Native Hawaiian and other Pacific Islander subgroups and also compared with >1.7 million non-Hispanic Whites. The study will address contemporary rates and prediction of incident heart failure, atrial fibrillation and acute myocardial infarction between these subgroups, along with linking comprehensive electronic health records, external data sources, patient self-reported data, as well as a biorepository of blood specimens to better evaluate potential exposures that may explain variation in major cardiovascular diseases across Asian American, Native Hawaiian and other Pacific Islander subgroups. Collectively, insights from the PANACHE Study will promote improvements in personalized care and cardiovascular outcomes across different Asian American, Native Hawaiian and Pacific Islander subpopulations which represent the fastest growing set of ethnic groups in the U.S.